RADX INNOVATION FUNNEL FOR HIV DIAGNOSTICS - COMMERCIALIZATION CENTER

The National Institutes of Health (NIH) Rapid Acceleration of Diagnostics (RADx®) Tech program was established to accelerate regulatory review and availability of high-quality, accurate, and reliable diagnostic tests. This project will generate evidence to support development of innovative HIV viral load testing platforms that are designed for use at the point of care.